Isolation and profiling of antibodies targeting SARS-CoV-2

A promising therapeutic and prophylactic strategy against COVID-19 is passive immunization through the transfer of anti-SARS-CoV-2 neutralizing antibodies and convalescent serum. However, there is growing evidence that antibody responses to the virus can also directly contribute to lethal immunopathology and hyperinflammation present in severe COVID-19 disease. Understanding the distinct mechanisms whereby humoral responses to SARS-CoV-2 provide protective antiviral immunity versus harmful immunopathology is thus essential in developing effective treatments for COVID-19. Furthermore, analysis of antibody responses in SARS-CoV-2-infected individuals will inform development of effective SARS-CoV-2 vaccines and reliable serological tests in the immediate future. Here, we propose to identify and characterize COVID19 patients’ anti-SARS-CoV-2 antibodies and the epitopes on SARS-CoV-2 that are targeted by immune responses. The goals of the proposed research are to identify potent neutralizing antibodies against SARSCoV-2 that can be advanced as therapeutic drug candidates and elucidate potential roles for deleterious autoreactive cross-reactivity of humoral responses to the virus. Our working hypothesis is that anti-SARSCoV-2 antibody responses generate neutralizing protective antibodies in most subjects, whereas S1 spike protein-reactive antibodies may cross-react with self-antigens expressed on lung epithelial cells in patients severely affected by the virus as suggested by a previous SARS-Cov study. We therefore propose to isolate and produce in vitro anti-SARS-CoV-2-reactive neutralizing recombinant antibodies cloned from memory B cells and plasmablasts from the blood of patients and asymptomatic infected subjects. We will profile cloned recombinant antibodies and COVID-19 patient plasma samples for reactivity against a large panel of conformational SARS-CoV-2 antigens as well as extracellular/secreted human proteins to identify humoral responses that may contribute to viral clearance and COVID-19 immunopathology, respectively. Responses to extracellular SARS-CoV-2 antigens will be determined using a multiplex flow-cytometry based assay that enables simultaneous quantification of humoral responses against multiple viral proteins as well as a qualitative assessment of their ability to block the interaction of SARS-CoV-2 spike protein with its entry receptor ACE2. Potential autoreactive responses elicited by SARS-CoV-2 infection will be assessed using a technique called REAP (Rapid Extracellular Antibody Profiling), in which serum/antibodies are panned against a comprehensive library of >3,000 human extracellular proteins displayed on the surface of yeast. These studies will thus provide insight into the development of immune responses targeting SARS-CoV-2, identify potent neutralizing antibodies against SARS-CoV-2 that can be advanced as therapeutic drug candidates and may suggest therapeutic strategies to attenuate potentially pathogenic antibody responses.

Public health relevance
OVERALL PROJECT NARRATIVE The overarching mission of Yale Cancer Center (YCC) is to understand and prevent cancer, detect cancer early, and manage more accurately and effectively cancer treatment. YCC is committed to fulfilling these goals by supporting collaborative research and education activities aimed at delivering the highest quality patient- centered care, achieving breakthrough discoveries, and training future leaders in cancer science and medicine.